Elucidating the heterogeneity of impaired awareness of hypoglycaemia in type 1 diabetes

1 Project Summary / Abstract
2 Impaired Awareness of Hypoglycemia (IAH) in people with type 1 diabetes (T1D) is associated
3 with defects in physiological counterregulatory and symptom responses to hypoglycemia as
4 leading to increased risk of severe hypoglycemia (SH). Education and technologies such as
5 hybrid closed loop (HCL) insulin delivery reduce hypoglycemia exposure, but restoration of
6 awareness is variable. Existing tools for screening and measuring awareness, such as Clarke
7 and Gold scores lack sensitivity to detect changes in hypoglycemia awareness in the CGM
8 era of “electronic awareness”. Therefore, we need to construct and validate more advanced
9 tools that can objectively assess IAH. This project seeks to understand the factors that
10 contribute to the successful restoration of awareness of hypoglycemia using HCL in
11 those with T1D and IAH and validate the tools required to assess changes in awareness
12 status. To address the specific questions in the call, we propose 5 sub-studies.
13 1. Study 1: To understand the physiological responses to experimental hypoglycemia in T1D
14 with NAH and the impact of a switch to hybrid closed loop on these responses over time.
15 2. Study 2: To determine if reducing exposure to biochemical hypoglycemia by switching to
16 state of the art hybrid closed loop technology can restore physiological responses to
17 experimental hypoglycemia over time in individuals with T1D and IAH
18 3. Study 3: To determine if hypoglycaemia specific education (HARPdoc) that addresses
19 cognitions and beliefs associated with IAH that are possible barriers to hypoglycemia
20 avoidance (even with technology) leads to further reductions in hypoglycemia exposure
21 and improved physiological responses to hypoglycemia in individuals with T1D and IAH
22 4. Study 4: To determine the factors associated with restoration of physiological responses
23 to hypoglycemia. We will categorise participants into Restored (R-IAH), Partial ( P-IAH) or
24 Sustained (S-IAH) impaired awareness of hypoglycemia based on changes in physiological
25 (epinephrine and symptom) responses to experimental hypoglycemia in clamp studies and
26 investigate demographic, glycemic and behavioural factors associated with each category.
27 5. Study 5: To determine diagnostic cut-offs for Normal, P-IAH and S-IAH responses to
28 experimental hypoglycemia for current self-report questionnaires and a novel tool named
29 the HypoMETRICS app. We will also use the HypoMETRICS app to explore differences
30 between “physiological” and “technological” awareness of hypoglycemia.

Public health relevance
Project Narrative Repeated hypoglycemia can blunt the usual protective physiological symptomatic and hormonal responses to hypoglycemia, leading to impaired awareness of hypoglycemia that affects up to a third of people living with type 1 diabetes and puts them at increased risk of the morbidity and mortality associated with severe hypoglycemia. Advances in patient education and technology, including continuous glucose monitoring systems and hybrid closed loops can reduce the exposure to hypoglycemia, but have demonstrated limited ability to restore impaired protective counter regulatory and symptom responses to hypoglycemia. The overall objective of this project is to provide a better understanding of demographic, glycaemic and behavioural factors that contribute to restoration of awareness of hypoglycemia, including normalisation of symptomatic and hormonal responses to hypoglycemia, and develop better tools for allowing us to assess awareness and changes in awareness status.